Targeting Feedback Circuitry for Antiviral Therapy

PROJECT SUMMARY/ABSTRACT
The human herpesvirus 5 (cytomegalovirus, CMV) infects >50% of the world’s population and causes substantial
morbidity and mortality in immunocompromised persons. There is no approved vaccine and CMV is a leading
cause of transplant failure and of birth defects. The current standard-of-care therapy for CMV (ganciclovir, GCV),
suffers from rapid evolution of viral resistance arising from the extensive CMV genetic diversity in patients and
there is an unmet clinical need for more effective CMV antivirals with high barriers to resistance. The long-term
goal of this work is to develop antivirals that are resilient to the evolution of resistance. The specific objective of
this proposal is to determine if targeting and disrupting viral transcriptional feedback circuits is a viable antiviral
strategy with a high genetic barrier to the evolution of resistance. Over the past decade our studies characterized
CMV’s master transcriptional circuit, a negative-feedback (i.e., auto-repressive) circuit called the immediate-early
(IE) circuit. We discovered that this negative-feedback circuit functions to maintain homeostatic levels of the
immediate-early 2 (IE86) protein, which is essential for CMV replication but also highly cytotoxic. Based on the
conserved nature of this negative-feedback loop, we developed strategies to disrupt negative feedback and
‘open the loop’, generating cytotoxic levels of IE86 and dramatically inhibiting viral replication. Resistance to
“open-loop lethality” is high and requires evolution of a genetically orthogonal feedback loop—a high genetic
barrier—and led to our development of DNA duplexes that competitively inhibit feedback, now termed “feedback
disruptor (FD) molecules”. Our extensive preliminary data show that FD molecules generate open-loop lethality
in virus-infected cells, leading to multi-log (>100x) reduction in virus titers and protecting CMV-infected mice from
death without detected toxicity. Based on these extensive preliminary data in animals, our central hypothesis is
that disruption of IE feedback circuitry is a pharmacokinetically viable strategy with a high barrier to the evolution
of resistance. The rationale for the FD approach rests upon our development of escape-resistant antivirals for
other rapidly mutating viruses and an established body of literature demonstrating that recapitulating disrupted
feedback loops carries a high genetic cost. The specific aims will test our hypothesis that feedback is
pharmacokinetically druggable and resilient to the evolution of resistance by: (i) developing a new type of PK/PD,
viral dynamics model of feedback disruptors to aid clinical translation of the antiviral strategy, (ii) testing if
silencing of cell-death pathways is a mechanism for resistance to FD ‘open-loop lethality’ and (iii) determining
the minimal viral genetic modifications that enable mutational escape from FDs, or if the resistance barrier can
be overcome. These studies will have broad significance in establishing transcriptional feedback as a druggable
target and quantifying the resistance barrier. Payoffs will be a first-in-class antiviral that could catalyze a new
drug paradigm targeting feedback circuitry.

Public health relevance
PROJECT NARRATIVE CMV infection is a leading cause of congenital birth defects and both solid-organ and bone-marrow transplant failures and is a major unmet medical need due to resistance to current antiviral therapeutics. This project will lay the foundations for a new class of antivirals that disrupt viral transcriptional feedback circuits, a ubiquitous biological regulatory mechanism utilized by many viruses. This therapeutic strategy could enable new classes of drugs targeting diverse feedback circuits, which are hypothesized to have a high barrier to the evolution of drug resistance.